BMPR2 mutations, Neointimal Transformation and Pulmonary Arterial Hypertension

Patients served by the Veterans Health Administration who have chronic cardiopulmonary conditions are at high
risk for death because of pulmonary hypertension (PH). A particularly dangerous form of PH, referred to as
pulmonary arterial hypertension (PAH), is a vascular disease with high prevalence and poor survival among US
veterans. PAH is characterized by gene variants, chronic inflammation and an occlusive remodeling of the
vascular intima (neointima). Heterozygous germline mutations in BMPR2 (bone morphogenetic protein receptor
2) is the principle genetic risk factor for hereditary PAH. There is an unmet need to understand how
environmental cues induce PAH in otherwise healthy BMPR2 mutation carriers.
We recently showed in a new ‘2-hit’ rat model that Bmpr2 mutations, when coupled with pulmonary inflammation,
elicit severe PAH in otherwise phenotypically-silent Bmpr2+/- mutant rats. PAH in this model features a
proliferative and inflammatory neointima with characteristics shared by human disease. TGF-b blockade
ameliorates advanced PAH and neointimal transformation in Bmpr2+/- animals and is a promising clinical therapy.
Pilot single cell RNA-seq analyses of the disease rat lungs revealed that Bmpr2 mutations and an inflamed lung
microenvironment cause a ‘transcriptional convergence’ of endothelial cells (ECs, originating from pulmonary
arteries, arterioles and capillaries) to form the transformed neointima. Based on these results, we postulate
that PAH occurs in Bmpr2 mutants because discrete endothelial transcriptional programs are modulated
and result in an inflamed neointima.
This proposal explores how genetic and environmental triggers may lead to neointimal formation and PAH at the
cellular and molecular levels; proposed studies also search for druggable targets driving EC transformation
following TGF-b treatment. Specific Aim 1 evaluates how Bmpr2 deficiency causes transcriptional
convergence of ECs to form the PAH neointima and has three subaims which are to establish a molecular
atlas of rat lungs in health and PAH using cutting-edge single molecular techniques (Aim 1a), then to elucidate
the cellular origins of neointima by tracking specific endothelial lineage cells in evolving disease (Aim 1b), and
finally to identify molecular programs responsible for the formation and maintenance of vascular lesions (Aim
1c). Specific Aim 2 explores how BMPR2 deficiency in human pulmonary arterial ECs provokes
proliferative endothelial inflammation and focuses on the influence of BMPR2 deficiency on inflammatory 5-
lipoxygenase (5-LO), NF-kB and IL-6 signaling. Here, the mechanisms by which BMPR2 insufficiency induces
5-LO epigenetic and post-translational modification, NF-kB transcriptional activities and classical- or trans-IL-6
signaling will be assessed. Specific Aim 3 tests whether TGF-b blockade reverses PAH by eliminating
transcriptionally-convergent ECs (i.e., neointimal cells) in the lungs of Bmpr2 mutant rats. This aim
investigates whether and how TGF-b inhibition reverses PAH by promoting the transcriptional ‘deconvergence’
of ECs and explores the reversibility and potential druggability of molecular targets. The overarching goal of this
proposal is to create a better understanding about the formation of the neointimal layer in PAH, a pathological
process responsible for vascular occlusion, high pulmonary artery pressures and right heart failure. These
studies may also offer clear directions for future therapeutic avenues of direct benefit to our veteran patients.

Public health relevance
US veterans with pulmonary arterial hypertension (PAH) are at a high risk for death. PAH is currently an incurable condition with higher prevalaence in veterans compared with the general population. BMPR2 gene mutations are the most important genetic risk factor for this disease. New research suggests that individuals with these mutations can develop PAH after lung inflammation when an abnormal growth of the inner layers of blood vessels (neointima) occurs. The neointima causes high blood pressure in the lungs, followed by heart failure and death. This proposal seeks to understand how BMPR2 mutations cause this dangerous transformation of pulmonary blood vessels so that life-saving therapies (targeting the neointima) may ultimately be developed.